Mitigation of peripheral nerve stimulation (PNS) in MRI

Project Summary/Abstract
Peripheral nerve stimulation (PNS) is the stimulation of motor and sensory nerves in the body by
electric fields induced by the rapid switching of MRI gradient coils. Until recently PNS was considered
an unavoidable effect of the MRI imaging process. This is problematic for clinical MRI because PNS
dramatically restricts the parameter space of common imaging sequences (TR, TE, ESP etc…) thus
resulting in degraded image quality and inefficient acquisition times. PNS is especially constraining
for fast ‘turbo’ sequences that have become ubiquitous in clinics, such as stead-state free precession
(cardiac), diffusion weighted imaging (neuro), turbo spin echo (cardiac/neuro/pelvis/knee) and fluid
attenuated inversion recovery (cardiac/neuro/pelvis/knee), just to name a few. In the previous funding
cycle, we developed, validated and disseminated electromagnetic and neurophysiological modeling
tools allowing to predict PNS thresholds in absolute unit (mT/m). We then proposed PNS mitigation
methods yielding gradient coils with intrinsically low PNS propensity.
Despite these successes, there are several barriers to clinical translation of our gradient designs.
A first challenge is the generation of coils that perform well for all body habitus (we currently consider
only two body models) and all imaging landmarks (we currently consider one landmark per
optimization). Another challenge is that of accurate real-time PNS monitoring as the patient is being
scanned. Indeed, the state-of-the-art PNS monitor, SAFE, does not model the variation of PNS
response across different landmarks, nor E-field interactions across gradient axes that occurs in
oblique MRI acquisitions. As a result, using SAFE for PNS monitoring does not allow using the full
performance capabilities of our PNS-optimized systems, and in general is poorly adapted to PNS
control in all high-performance systems. In this renewal, we design gradient coils with robust
PNS performance across all body habitus, imaging landmarks and develop accurate PNS
monitor models that allow using the full performance capabilities of high-performance
gradient systems, including our PNS-optimized designs. In the last Aim, we build gradient coil
prototypes to validate our PNS predictions in healthy subjects. A key deliverable of this project is the
dissemination of gradient design and monitoring tools that fully address PNS in MRI and can be
readily translated to industry and clinics. We work closely with academic, industry (Siemens, GE) and
regulatory partners (IEC, FDA) throughout the project to ensure translation.

Public health relevance
Project Narrative In the previous cycle we developed a detailed simulation of peripheral nerve stimulation (PNS) and proposed methods to mitigate PNS in MRI, which is key to improve the image quality and acquisition speed of MRI sequences commonly used in clinics. In this renewal application, we address remaining barriers to clinical and industrial translation of our methods in order to achieve robust PNS mitigation for all patients and all MRI examinations. To this aim, we extend our coil designs to reflect a diverse clinical population and examination landmarks, and propose improved PNS monitoring tools that allow full utilization of the performance gains brought by our designs.